LOSIGAMONE--EXTENSION OF A DOSE TOLERANCE STUDY

The purpose of this study is to provide continued evaluation of the safety of oral Losigamone in patients who have demonstrated clear benefit in seizure control.